Animal MRI/Imaging Core

The Animal MRI Core has performed MRI studies on 15 projects from Oct. 1, 2013 to Sept 30, 2014. Currently active projects are listed below, alphabetically by Principal Investigator: 1) Arai , Andrew; fellow, Pascale Beliveau. NHLBI protocol H-0176. Rat Myocardial Fibrosis. MRI microimaging of rat heart in experimental and age-related fibrosis, acute MI, and chronic MI. 2) Arai , Andrew; Epstein, Steven (Washington Hospital Center (WHC)); fellow Michael Lipinski (WHC). Imaging targeted and non targeted contrast agents in mouse myocardial infarction. 3) Boehm, Manfred; fellow Dan Yang. NHLBI Protocol H-0184. Vascular imaging, leg graft model, angiography. 4) Boehm, Manfred; fellow Cynthia St. Hilaire. NHLBI Protocol H-0038. Imaging teratoma anatomy, perfusion and vascular calcification (MRI and CT). 5) Boehm, Manfred; fellow Alejandra Negro. NHLBI Protocol H-0185. Imaging Marfan and Marfan cross mouse models for structural abnormalities in the atria and aorta. 6) Bustin, Michael (NCI); Takashi Furusawa, NCI. NCI protocol LMC-030. Characterization of cardiac function in HMGN KO and transgenic mouse lines Collaboration with Adelstein, RS (NHLBI). Continued manuscript work in FY 14. 7) Huizing, Marjan (NHGRI); fellow May Malicdan. NHGRI Protocol G04-3,. Cardiac function and stress testing in a mouse model of hypertrophy. 8) Moss, Joel; fellow Jiro Kato. NHLBI protocols H-0172R1, H-0193. Cardiac function on M and F DKO, ARHI, and LAM mice. We completed cardiac function on DKO and ARH1 mice. 9) Moss, Joel; fellow Gustavo Pacheco. Protocol H-0172. 3D body imaging and location of tumors and lymph node abnormalities in the abdomen on LAMS mice. 10) Moss, Joel, Fellow Xiangning Bu. Protocol H-0128. Imaging acute myocardial infarction in mice. 11) Moss, Joel, NHLBI; Darling, Thomas, Dept. of Dermatology, Uniformed Services University of the Health Sciences (USUHS); Fellow Peter Klover, USUHS. NHLBI protocol H-0028. Whole body imaging of TS-2 tuberous sclerosis. 12) Sack, Michael; NHLBI fellow, Kim Han. NHLBI Protocol H-0222. Imaging Parkin mouse model with TAC surgery (aortic banding). Assessment of functional and wall thickness response to aortic banding or sham surgery by MRI. 13) Segars, James, NICHD; fellow Kimberlyn Baig-Ward. NICHD protocol 12-060. Cardiac function and dobutamine stress testing on Brx (AKAP 13) mouse model. 14) Tabak, Lawrence, NIDCR. Protocol 14-722, Staff Scientist Thomas Beres. Cardiac function and anatomy for a study of Galnt1 deletion. Re-imaged in FY14. 15) Wen, Han, NHLBI. Microimaging a mouse kidney for comparison to an x-ray imaging technique by Han Wen in collaboration with Argonne National lab. Study was completed in FY 13 and published in FY14.